URCC NCORP Research Base

ABSTRACT: The University of Rochester Cancer Center (URCC) National Cancer Institute Community
Oncology Research Program (NCORP) Research Base (RB) is a RB with 35+ years of experience conducting
cancer control research (CCR) and cancer care delivery research (CCDR). The URCC NCORP RB’s vision is
"to help good people through lousy times when they experience cancer” by reducing cancer- and treatment-
related morbidity stemming from toxicities and side effects. Since 2014, 35% (N=2,831) of all NCORP accrual
credits resulted from enrollment of patients and survivors by our Community Affiliates on our 13 active URCC
clinical trials. URCC and its Community Affiliates also enrolled 421 caregivers and more than 300 oncologists to
our 13 active trials, as well as 1,752 patients and survivors to our 29 local pilot studies. URCC successfully
enrolled and randomized over 30 individual community oncology practices to cluster randomized trials. Our
investigators and staff submitted 8 new concepts/grants, with 18 new concepts/grants currently in development,
and 29 active pilot studies. The significant and innovative contribution of URCC research to scientific knowledge
and clinical care is evidenced by 1) 197 published manuscripts, 2) 209 presented abstracts, 3) 25 podium
presentations at ASCO, 4) 82 outstanding research awards to our investigators, 5) 12 junior investigators
successfully trained to conduct research in NCORP, and 6) 2,215 investigators, clinicians, and staff successfully
trained to implement URCC NCORP RB protocols at community sites across the United States. Notable
recognition of the significance of research conducted by the URCC RB and its investigators includes: 1) Best of
JCO publication for 2017, 2) most cited article in JAMA Oncology for 2017, 3) one of the most significant advances
in cancer research and care for 2018, 4) citation of our published research in virtually all existing supportive care
treatment guidelines, and 5) leadership by 5 of our RB Executive Committee members in the development of 4
supportive care treatment guidelines. We accomplish our goal of reducing cancer- and treatment-related
morbidity by working with cancer patients, survivors, and their caregivers from 592 community oncology practices
across the United States to design and conduct CCR and CCDR, including translational and health equity
outcomes, focused in symptom science. Our research develops and tests novel treatments for toxicities and
side effects stemming from cancer and its treatments. We design and conduct phase I-III randomized clinical
trials and longitudinal, prospective cohort studies. To meet its responsibilities as a RB and maintain its high level
of productivity over the next funding period, the URCC RB will focus its resources and expertise on the following
specific aims: Aim 1) to conduct CCR, Aim 2) to conduct CCDR, Aim 3) to conduct translational CCR, Aim 4)
to conduct health equity CCR and CCDR, and Aim 5) to provide state-of-the-art training and mentoring for
NCORP investigators and staff. With its proven track record of productivity and innovation, the URCC NCORP
RB is expertly positioned to continue its pioneering symptom science research in the NCORP Network.

Public health relevance
PROJECT NARRATIVE The University of Rochester Cancer Center National Cancer Institute Community Oncology Research Program Research Base is a legacy academic Research Base with 35+ years of continuous funding to conduct cancer control research and cancer care delivery research. Working within a large network of community oncology clinics across the United States, the goals of the Research Base and its community partners are to reduce cancer- and treatment-related symptoms and side effects by conducting research with cancer patients, survivors, and their caregivers.